Learn Systems Biology Equations From Snapshot Single Cell Genomic Data

Understanding how cells respond to environmental changes is a fundamental task in systems biology and has
profound biomedical implications. Mathematical modeling on small network motifs using dynamical systems
theories has been successful on providing mechanistic insight and guidance, but generalization to a genome-
wide intertwined gene regulatory network is challenging. Single cell genomics approaches emerge as powerful
tools for studying cellular processes, but the destructive nature of most single cell techniques makes it
unfeasible to extract dynamical information of cellular processes. In addition, a number of grand challenges
impede further development of the field, such as trajectory inference, effect of various sources of errors on
data analysis, and validating and benchmarking tools for single cell measurements and analyses. The goal of
this proposed research is to tackle these challenges through integrating dynamical systems modeling into
single cell genomics analyses. The proposed research is based on recent advances in the single cell genomics
field that one can extract both transcriptome (x) and estimation of RNA velocity (i.e., instant time derivatives of
transcriptome, dx/dt) from single cell genomics data. We further developed a unified theoretical framework that
allows estimating the velocity information from various types of single cell data, and a machine learning based
computational pipeline of reconstructing systems biology equations for genomewide regulatory networks,
together with a computer package, dynamo, released to the community. This integration between single cell
genomics analyses and systems biology modeling provides quantitative mechanistic and dynamics
information. We propose to further develop our package and computational framework to address several
limitations in our published work. In Aim 1, we will first develop dynamo to interface with other single cell
analysis and dynamics modeling packages, and expand the types of single cell data to be analyzed. Then we
will develop and test a discrete dynamical model for full stochastic cellular dynamics based on the graph
representation of discrete vector fields. In Aim 2, we will first develop a systematic pipeline of integrating data
of multi-modality (e.g., ATAC-seq, DNA sequencing and binding site analyses, etc) and dynamo to identify
genetic codes of combinatorial function of transcriptional factors, the so-called composite elements in genetics.
Eukaryotic cells use a combination of a finite number of transcription factors to generate a large number of
different target gene regulation patterns. Cracking the genetic code at the genome-wide level is fundamental to
cell biology but challenging despite extensive efforts. Then we will expand the pipeline to reconstruct biology-
informed systems biology models for the genomowide gene regulation. We will evaluate the in silico
predictions from the model against several Perturb-seq datasets.

Public health relevance
Single cell genomics data have become indispensable tools in studying physiological and pathological processes, and a grant challenge is to extract quantitative mechanistic information from the snapshot data. Our proposed research will develop a computational framework to reconstruct dynamical information from single cell genomics data. The research will provide a quantitative framework for extracting mechanistic information from single cell data that can guide on controlling cellular processes for biomedical purposes.